Comprehensive Liquid Biomarkers to Personalize Therapy in Renal Cell Carcinoma

PROJECT SUMMARY/ABSTRACT
Combination immune-oncology (IO) using immune checkpoint blockers (ICB) with or without vascular endothelial
growth factor (VEGF) targeting agents have emerged as first-line treatments for patients with advanced renal
cell carcinoma (RCC). Although the initial response rates to treatment range from 40%–60%, the rates of
treatment resistance are high. Given the need to better optimize therapy selection for patients and minimize
exposure to ineffective treatments, identifying which patients are destined to progress on treatment and those
who can obtain long-term benefit and potentially cure is an urgent need plaguing clinical practice. Currently, no
biomarkers are used in the clinic to help inform therapy selection for patients. Against this backdrop, we have
pioneered a minimally invasive comprehensive blood-based liquid biopsy platform that can integrate analysis of
CTC protein and DNA—necessary for improved treatment selection for patients with RCC and other cancers.
The key aims of this project are to: 1) clinically validate early on-treatment CTC dynamics as prognostic
biomarkers in metastatic RCC, 2) clinically validate early on-treatment CTC dynamics as predictive biomarkers
to IO therapy in metastatic RCC, and 3) determine if early on-treatment CTC dynamics predict benefit to
stereotactic ablative radiotherapy (SABR), which is increasing being utilized in RCC management. We will use
our liquid biopsy platform to identify predictors of response and resistance to systemic therapy and radiotherapy
among two clinical groups of advanced RCC patients: (1) a multi-institutional cohort of patients with RCC from
University of California San Diego Moores Cancer Center, University of Wisconsin Carbone Cancer Center, and
University Hospitals Seidman Cancer Center, and (2) RCC patients enrolled on a nationally-accruing, National
Cancer Institute Cooperative Group trial of IO combination therapy with or without SABR. The outcomes of this
project will transform how we select patients for treatment and monitor for resistance in metastatic RCC. Our
team is led by Dr. Rana R. McKay, an early-stage investigator and medical oncologist at the University of
California San Diego. Together with Dr. Zhao, Lang, and Emamekhoo from the University of Wisconsin, and Dr.
Barata from University Hospitals, we have the clinical and translational expertise necessary to lead the studies
featured in this project. We are confident that our innovative, minimally invasive, liquid biopsy approach will
provide real-time molecular information for clinical decision-making that will optimize therapy selection of patients
and improve patient well-being by maximizing the therapeutic benefit of treatment and limiting exposure to
ineffective treatments. Additionally, our approach is scalable allowing for broad clinical application. Our proposed
comprehensive clinical-grade liquid biopsy platform will revolutionize developing biomarkers for RCC and can
serve as a roadmap for other cancers.

Public health relevance
PROJECT NARRATIVE Although immune checkpoint inhibitors (ICI) have improved the treatment of advanced renal cell carcinoma (RCC), patient responses to treatment vary, and rates of acquired resistance are high. Against this backdrop, we have pioneered a minimally invasive comprehensive blood-based liquid biopsy platform that can integrate analysis of circulating tumor cell protein and DNA—necessary for improved treatment selection for patients with RCC and other cancers. We will use our liquid biopsy platform among an institutional cohort and currently accruing phase 2 National Cancer Institute (NCI) sponsored study of advanced RCC patients to identify predictors of response and resistance to ICI and radiotherapy, which will not only improve their outcomes to treatment through better selection of therapy, but also potentially improve the treatment optimization of all cancer patients undergoing a variety of other cancer therapies.